Tissue specific immunity to fungal infections

Project summary/abstract
Candida albicans is a major opportunistic fungal pathogen of humans, which colonizes mucosal surfaces (oral, gut, vaginal
tract) in many individuals and can cause serious systemic (i.e., invasive candidiasis) and mucosal infections (e.g.
oropharyngeal candidiasis) in immunocompromised patients. Although it is well established that the oral mucosal and
systemic infection niches impose differential immune pressures on C. albicans, the mechanisms by which C. albicans adapts
to such distinct environments are still very poorly understood. This proposal is built on the hypothesis, supported by our
extensive preliminary data, that C. albicans adaptation and virulence in these distinct host niches require the Gcn5 lysine
acetyl transferase, which acetylates different sets of cellular proteins during invasive vs. oral infection, thus regulating their
activities during the host-pathogen interaction. Gcn5 is known to play a key role chromatin remodeling and the regulation
of gene expression. Our preliminary studies have revealed that Gcn5 is essential for antifungal drug resistance and for
virulence in both the oropharyngeal as well as the invasive candidiasis mouse models. We have identified Eaf3, a Gcn5
acetylation substrate that may be important for C. albicans virulence in an organ specific manner.
Thus, despite clear evidence for acetylation-mediated contributions to fungal pathogenesis, there is a knowledge gap in our
understanding of how fungal the acetylome change in vivo during infection and organ dissemination. Thus, there is a critical
need to analyze fungal pathogens recovered directly from host niches in vivo, where they encounter complex and dynamic
immune defense. The overall objective in this application is to decipher how Gcn5 mediated acetylation are modified in vivo
in response to host immune defenses in a niche-specific manner. These objectives are strongly supported by preliminary
data, which shows that Gcn5 target Eaf3 is specific for virulence in invasive candidiasis and the acetylation of Eaf3 is
required for niche specific virulence of C. albicans. Based on the preliminary data, our central hypothesis is that Gcn5
regulated acetylome confer distinct adaptive capacities to C. albicans, depending on niche-specific host defenses. We will
test our central hypothesis and accomplish our objective by pursuing two Specific Aims. 1) Identify the in vivo targets of C.
albicans Gcn5 in a murine model of oropharyngeal candidiasis and characterize their roles in the fungal interaction with
mucosal immunity. 2) Identify the in vivo targets of C. albicans Gcn5 in a murine model of invasive candidiasis and
characterize their roles in the fungal interaction with systemic immune system. The payoffs of this proposal are expected to
be significant because we expect to uncover organ/tissue specific determinants of C. albicans virulence.

Public health relevance
Project Narrative The proposed research is relevant to public health because the identification and characterization of niche specific gene regulatory networks and in vivo acetylome will highly likely uncover novel modes of regulation of key cellular processes important for pathogenesis of C. albicans in addition to fundamentally advancing the field of Candida and candidiasis. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burdens of human disease.